Drifting to victory: resolving the paradox of M. tuberculosis evolution

PROJECT SUMMARY/ABSTRACT
Tuberculosis (TB) is the leading cause of death due to an infectious disease worldwide. Although TB is treatable,
treatments are prolonged, complex, and difficult for many people to tolerate. Mycobacterium tuberculosis (M. tb)
also readily acquires drug resistance and global efforts to control TB are threatened by the increasing problem
of drug resistance. M. tb is capable of assembling into biofilm communities capable of withstanding lethal doses
of antibiotics and this phenomenon likely contributes to difficulties in treating and controlling TB. We have
developed an in vitro system to study adaptation M. tb within biofilms. Leveraging analyses of these experimental
populations with those of a well characterized natural population of M. tb, we discovered that M. tb strains
separated by a small number of genetic differences exhibit a surprising array of phenotypic differences. Our
preliminary data point to regulatory mechanisms underlying these changes. Contextualizing these data with our
recent discoveries in M.tb evolutionary population genomics at regional and global scales, we hypothesize that
M. tb adaptation occurs at the scale of individual hosts while large scale phenomena act primarily as a constraint
on adaptation. Our major objective now is to delineate the mechanisms underlying observed phenotypic
differences in these natural and experimental populations.

Public health relevance
NARRATIVE Tuberculosis is the leading cause of death due to infectious disease worldwide. The goal of this proposal is to better understand evolution of the causative agent, Mycobacterium tuberculosis, in order to enable development of more effective strategies to treat and control TB.